Engagement Core

Engagement Core
Project Summary/Abstract
The unifying themes of the Engagement Core are (1) facilitation of bidirectional engagement with the community by all Center investigators, (2) removal of barriers to access to services for children with SLDs, (3) translation and dissemination of the results of the CLDRC to families, scientists, practitioners, and policy communities, and (4) development of project-based career-enhancing opportunities for CLDRC mentees and engaged members of the community. Core objectives will be accomplished by facilitating access to comprehensive SLD assessments for all families, developing individualized mentorship plans and implementing an effective publication plan that ensures that mentees have opportunities to serve as lead and corresponding authors, and facilitating bidirectional sharing of knowledge with the community by all CLDRC investigators, including support for specific skill development for community members who are engaged with the CLDRC.